Project 2: Systemic Understanding of Cellular Mechanisms of Metabolic Adaptations in Cancer

ABSTRACT
Metabolic alterations are a fundamental characteristic of tumorigenesis, suggesting that better understanding of cancer specific metabolic dependencies may yield novel targets for cancer therapy. Better understanding of how cancer cells adapt to metabolic challenges would provide opportunities to design novel therapeutic interventions to prevent these changes or target the novel liabilities they generate to improve outcomes for cancer patients. During research conducted as a part of our U54 Pilot Project, we established a novel experimental system to study metabolic alterations during tumorigenesis by identifying metabolic changes required to support cell proliferation in cancer cells with impairments in the mitochondrial enzyme succinate dehydrogenase (SDH, also known as complex II of the electron transport chain (ETC)). SDH is a tumor suppressor in several cancer types and loss of function mutations in SDH cause a complete block of oxidative tricarboxylic acid (TCA) cycle activity at the SDH step. Investigating the metabolic consequences of SDH loss, we found that acute SDH loss caused an aspartate-dependent defect in cancer cell proliferation but, over the course of months, chronically SDH deficient cells progressively adapted to mitigate the proliferation defects of SDH loss. Tandem-mass-tag proteomics of mitochondria from cells along the adaptation process revealed that adaptation was associated with a progressive decrease in protein expression of ETC complex I (CI) subunits. This effect was found to be causal for adaptation since acute treatment with CI inhibitors rescued the proliferation of early passage SDH deficient cells and restoration of CI activity was deleterious to cells with long term adaptation to SDH loss. These results identify a novel metabolic adaptation for cancer cell proliferation upon the loss of the tumor suppressor SDH and provide a defined system to better understand how cells enact adaptive metabolic expression changes. Here, we propose to use metabolic alterations and polyomic profiling combined with bioinformatic analyses and machine learning approaches to understand the biological mechanisms used by cancer cells to enact adaptive metabolic reprogramming in this cancer model and extend our findings into human tumor datasets. We hypothesize that these approaches will identify mechanisms by which cancer cells adapt to metabolic bottlenecks and allow for the identification of functionally important metabolic changes that support cancer progression.

Public health relevance
This Full Project combines the expertise of cancer metabolism research and biostatistics to deepen our understanding of the mechanisms of metabolic adaptation. The multidisciplinary collaboration enhances cancer research education opportunities by transferring knowledge of metabolism and statistics across institutions and student training levels. The team members will benefit from cancer/biostatistics and career development workshops supported by the Research Education About Cancer and Health (REACH) Core. Drs. Jeon and Sullivan will also interact with the Resource for AcademIc SuccEss (RAISE) Core by participating in mentoring and career planning activities for early-stage investigators. The project members and students will disseminate research findings and their experiences to communities in our catchment areas in collaboration with the Outreach Core. The Full Project team will foster positive scientific environments through joint meetings between Jeon and Sullivan’s groups of researchers, promoting all students to increase their cancer research experience and enhancing opportunities to reinforce their science identity. This Full Project will advance the Partnership, strengthening cancer research capabilities through a new, synergistic collaboration between NMSU and Fred Hutch researchers. This commitment to training and mentoring scientists will also support community engagement and health outcomes.